Community Outreach & Engagement

PROJECT SUMMARY: COMMUNITY OUTREACH & ENGAGEMENT (COE)
The catchment area of the Fred Hutch/University of Washington Cancer Consortium includes 13 counties in
western Washington (WA). This area has 5.03 million individuals of whom 32.3% are racial/ethnic minorities.
Consortium leadership defined the catchment area to include the vast majority of incident cancers seen by the
Consortium, with 83% of Consortium cases arising from this area.
The Office of Community Outreach & Engagement (OCOE), established in 2017 by the Consortium, grew from
the Health Disparities Research Center which was founded by Fred Hutch in 2010 and gained funding from the
2015-2019 Cancer Center Support Grant (CCSG). Since 2017, the Consortium OCOE led a needs
assessment process to define the cancer burden in the catchment area and comprehensively identify and
guide efforts to address the cancer burden and inequities. The top five cancer sites for incidence and mortality
include lung, breast, prostate, colorectal, and hematologic malignancies. The largest inequities for cancer
incidence and mortality were among American Indian and Alaskan Natives (AIAN) and non-Hispanic blacks
(NHB). Rural counties furthest from the Consortium sites also had the highest cancer incidence and mortality.
Our goal is to attain health equity for all individuals, regardless of their race/ethnicity, socioeconomic status,
geographic residence, or any other potentially limiting factor. Therefore, the specific aims of the OCOE are to:
1. Define and continuously monitor the cancer burden in the catchment area
2. Use an equitable, bidirectional approach to implement outreach and inreach education and programs to
reduce the cancer burden in the catchment area
3. Promote research relevant to the catchment area to reduce the burden of cancer, including research
between catchment communities and the Consortium
4. Continue and expand cancer research in high need areas beyond the catchment area
To achieve these aims, the OCOE has made the needs assessment a continuous process and convened a
Community Action Coalition, consisting of stakeholders representing all 13 catchment area counties, to review
and guide our response to the dynamic needs of the area. Working with communities in the catchment area,
the OCOE supports an expanded outreach and research infrastructure, which includes expansion of patient
navigation and community health educators to promote engagement of catchment area populations as well as
a new catchment-focused pilot grants program, all of which include an additional emphasis on those with the
highest cancer inequities (i.e., AIAN, NHB, and rural populations).

Public health relevance
Not applicable to P30 CCSG as stated in the FOA PAR-17-095.